Administrative Core

Administrative Core Summary
The administrative structure and operation of JH-TIE is designed to achieve four specific administrative aims of
the Center: (1) Facilitate collaboration among and across the three TR&Ds, the Training and Dissemination team,
and the External Advisory Committee (EAC), bringing together immunologists and engineers; (2) Enhance
synergies among the JH-TIE team and with the co-investigators of the Collaborative and Service projects; (3)
Enable the leadership team to effectively manage the Center, including supporting rapid decision making and
effective resolution of conflicts; and (4) Ensure effective utilization of NIH funds and JHU funds, facilities, and
other resources. JH-TIE is managed by an Executive Board whose membership includes Center Directors
Jonathan Schneck and Jordan Green, and the PIs of each TR&D and Training and Dissemination. JH-TIE
includes regular scheduled meetings for each TR&D, as well as of the Executive Board and EAC. JH-TIE
includes a dedicated functional hub for Training and Dissemination. JH-TIE is supported by a pair of experienced
administrators, and each TR&D PI will manage use of equipment and facilities in their respective TR&D area.
JH-TIE will utilize a proven framework for identifying and protecting intellectual property to maximize the impact
of the Center’s research, and will leverage a designated licensing staff member.